Environmental Health Research for Teachers and High School Students (EARTH) in the Great Northern Plains

Project Summary
The mission of this application is to develop a structured, on-site summer environmental health sciences
research program for high school teachers and students from three rural, Indigenous communities in the
Northern Plains. The proposed program is a collaboration between the Columbia University Mailman School of
Public Health (MSPH) Department of Environmental Health Sciences (EHS) and Missouri Breaks Industries
Research Inc. (MBIRI), an American Indian-owned research center serving these Indigenous communities and
others in the Northern Plains. We propose the EARTH program (Environmental HeAlth Sciences Research for
Teachers and High School Students), to establish a structured summer environmental health sciences (EHS)
research program for high school teachers and students in these three communities. Research projects will be
locally relevant and reflect the priorities and values of the communities, leveraging EHS research that is already
taking place in these communities through collaboration with Columbia University and MBIRI researchers. One
teacher-student group from each community, comprised of one science teacher and 2-4 highly motivated high
school students, will be actively mentored through an EHS summer research project with support from expert
research mentors from both Columbia University and MBIRI. Research mentor teams will provide structured
workshops and educational training to teachers and students, and assist teams in developing and executing the
research project over the course of the summer through structured meetings. EARTH teacher-student teams
from all three communities will meet with the Program Directors and research mentors three times a week for
educational seminars relevant to conducting EHS research, science communication, and research translation,
and to share research progress updates in collaborative workshops. By the end of the summer period, teacher-
student teams will have prepared formal scientific presentations and infographics of their projects to be presented
at the EARTH Mini Symposium. Teams will also present their findings to the community advisory group at MBIRI,
to their classrooms during the following school year, and at MBIRI’s annual Research Symposium in the following
spring. Teachers will present their findings in virtual academic seminars at Columbia University. In addition to
these research and communication experiences, students will receive substantial mentorship and support in
preparing applications for undergraduate/training school programs and employment opportunities in EHS/STEM.
Teachers will also receive support to develop curriculum programs that they can implement in their classrooms.
By engaging high school students early in their training and exposing them to the broad range of environmental
health disciplines, we seek to support students from Indigenous communities to pursue careers and further
education in environmental health sciences.

Public health relevance
Project Narrative This application aims to develop a structured, on-site summer environmental health sciences research program for high school teachers and students from three Indigenous communities in the Northern Plains. High school teacher-student teams will conduct high-quality, locally relevant environmental health sciences research through collaboration with Columbia University and Missouri Breaks Industries Research Inc (MBIRI) researchers that collectively have decades of experience in environmental health sciences research. Through this research as well as through developing professional skills, both for students and teachers, we ultimately aim to enable the participants to pursue research and professional careers in environmental health sciences/STEM, and, ultimately, to contribute to the prevention and control of diseases of environmental origin inclusively and with diverse perspectives.